Electronic Cigarette Use among American Indian Women

Abstract
Smoking during pregnancy is associated with serious and adverse outcomes for mothers and their infants.
American Indian/Alaska Native (AI/AN) women have higher prevalence of smoking and poorer tobacco-related
birth outcomes compared to other racial/ethnic populations. People who smoke are increasingly using
electronic cigarettes (e-cigarettes) to quit smoking or reduce cigarette consumption. Since e-cigarettes have
substantially lower levels of certain toxins compared to cigarettes, pregnant women may switch to these
products in order to reduce the known risks associated with smoking. While e-cigarettes contain fewer toxins
compared to cigarettes, these products still contain elements that may be harmful to the fetus, including
nicotine. Yet, relatively few studies have evaluated e-cigarette use in pregnancy or the effects of e-cigarette
use on birth outcomes. Further, no studies have assessed e-cigarette use among AI pregnant women, a
population disproportionately affected by tobacco-related poorer birth outcomes. This observational cohort
study will provide new insight into e-cigarette use and its association with birth outcomes, and harm versus
benefit perceptions during pregnancy among 300 American Indian women receiving prenatal care at Cherokee
Nation Health Services, using biochemical verification of toxicant exposure and smoking cessation, including
cotinine, metabolite of nicotine, carbon monoxide, and survey data. We will pursue the following specific and
exploratory aims: 1) Describe baseline prevalence of e-cigarette and other tobacco use, cotinine levels, and
patterns of e-cigarette use among adult pregnant AI women in their first trimester; 2) Describe the baseline
perceptions about the health risks related to tobacco and e-cigarette use during pregnancy and how they are
associated with tobacco and e-cigarette use patterns; 3) Among the group of AI women in SA1 who used
tobacco or e-cigarettes at baseline or within 3 months of pregnancy, explore the feasibility of reassessing
smoking and e-cigarette use and cotinine exposures in the third trimester of pregnancy. We will explore the
feasibility of recruiting and retaining pregnant AI women in a longitudinal study to assess product switching,
changes in cigarettes smoked per day, change in nicotine exposure, and smoking cessation through
pregnancy; 4) Assess the prevalence of low birth weight and preterm birth among infants born to AI women by
e-cigarette and tobacco use status. We will explore the feasibility and acceptability of using medical records to
assess birth outcomes overall and by baseline e-cigarette use and smoking status. E-cigarette use may
potentially mitigate some of the health effects associated with cigarette use. Our project promises to illuminate
patterns of e-cigarette use and its association with toxicant exposure in pregnancy and birth outcomes in a
racial subpopulation disproportionately affected by tobacco-related diseases.

Public health relevance
Narrative Electronic cigarettes (e-cigarettes) are increasingly being used by people who want to reduce or quit smoking, and these products have the potential to reduce the risks related to smoking, including the risks of smoking during pregnancy. However, these products still contain components that are associated with toxins that lead to poorer birth outcomes. It is important to understand the prevalence of e-cigarette use among pregnant women and implications for birth outcomes, especially among American Indian/Alaska Native pregnant women, a population disproportionately affected by tobacco-related diseases.